EFFECT OF GEMFIBROZIL ON TRIGLYCERIDE LEVELS IN PATIENTS WITH TYPE II DIABETES

Objective is to determine if Gemfibrozil will reduce triglyceride levels in Type II diabetic patients independent of diabetes control and nutritional regulation.